Center for Transformative Infectious Disease Research (CTIDR)

Some of the greatest human health impacts from infectious diseases are influenced by
weather events and seasons. Billions are at risk annually from rainfall-dependent malaria,
and viral pathogen spillover events and spread of vector-borne diseases (VBD) are
increasing due to extreme weather events. In response to these urgent threats, Cornell
University has created the Center for Transformative Infectious Disease Research
(CTIDR). To have the greatest health impacts, we must change research and practice
paradigms from reactive focus on response to outbreaks to proactive understanding of
the complex social and environmental conditions that promote risk of outbreaks. We
hypothesize that community-engaged research integrating human, reservoir and vector
behavior, weather, land-use, human and animal health, and vector/pathogen genomic
evolution datasets, will enable creation of predictive epidemiological models and future
generation and rigorous testing of preventative interventions. Working toward these
goals, CTIDR’s Community Engagement Core (CEC) will intersect with and support the
aims of the Administrative Core, Living Evidence Data Core, Project 1 Research Team
(extreme weather events and land use changes result in wildlife-to-human viral spillover
events), and Project 2 Research Team (community-based early warning system for
weather-sensitive VBD can promote human health), and will specifically work to foster
collaborative, community-engaged research teams that generate hypotheses and extend
projects, and generate and use data to improve infectious disease prevention and
community resilience. The CEC will build upon robust community engagement seeded
by CTIDR members, and augment approaches and outcomes under the leadership of
CEC lead Meredith (ESI). Over the next 3 years, to build reciprocal community engaged
research relationships for the future, the CEC will (1) Promote and enhance community
engagement in guiding CTIDR’s work by establishing community-embedded action
research partnerships, and creating standard processes and venues to support
communication of community ideas, issues, needs, and concerns to CTIDR’s members
to inform and guide research activities that address community needs; (2) Aid
communities in using CTIDR data and research to spur systems change by advancing
partner communities’ public health literacy, including via sharing data and CTIDR
research results into plain, action-focused language; and (3) Establish benefits and
scalability of the CEC approach by applying mixed methods developmental evaluation to
document processes, resource needs, outputs, and outcomes derived from CEC
actions. Anticipated outcomes include active hypothesis-driven CBPR projects and
documentation of expanded capacity and process/ systems change showing how
research is being used by communities to improve infectious disease prevention, and
resilience against the complex impacts of extreme weather events.